RUNX3 in Vascular Wall Remodeling

Project Summary
Vascular smooth muscle cell (VSMC) phenotypic modulation, a phenotypic switch from a differentiated
contractile phenotype to a proliferative phenotype, contributes to vascular remodeling and the development of
diverse vascular diseases such as atherosclerosis, hypertension, and restenosis following angioplasty.
However, the molecular mechanisms that control VSMC phenotypic modulation are poorly understood. Our
exciting preliminary data strongly support a novel role of Runt-related transcription factor 3 (RUNX3) in VSMC
phenotypic modulation. RUNX3 belongs to the ‘Runt domain’ family of transcription factors that act as
regulators of gene expression in several important developmental pathways. We found that RUNX3 expression
is significantly increased by platelet-derived growth factor-BB (PDGF-BB), a potent stimulator of VSMC
phenotypic modulation. Knockdown of RUNX3 reversed PDGF-BB-inhibited expression of SMC contractile
markers. In addition, RUNX3 knockdown blocked PDGF-BB-induced VSMC proliferation. These data
demonstrate that RUNX3 is essential for PDGF-BB-induced VSMC phenotypic modulation and cell proliferation
in vitro. In addition, RUNX3 overexpression blocked myocardin-induced α-SMA expression and promoter
activity, suggesting that RUNX3 regulates VSMC contractile marker expression through myocardin/SRF
signaling. RUNX3 knockdown also inhibited PDGF-BB induced expression of c-Myc, a crucial driver of VSMC
proliferation. The PDGF-BB-induced activation of NF-κB and phosphorylation of GSK3β, important pathways in
regulating c-Myc levels, were adversely affected by RUNX3 knockdown. RUNX3 expression was activated in
the media and neointima VSMCs following the left common carotid artery injury in C57BL/6 mice. RUNX3
deficiency (RUNX3-/-) dramatically inhibited injury-induced neointima formation, suggesting that RUNX3 plays a
critical role in injury-induced neointima formation and vascular remodeling in vivo. These data together strongly
support a novel hypothesis that RUNX3 induces VSMC phenotypic modulation by suppressing VSMC
contractile marker expression and promotes VSMC proliferation via c-Myc, leading to neointima
formation/vascular remodeling, which will be tested by three Specific Aims. Aim 1: Determine the molecular
mechanisms underlying RUNX3 function in modulating VSMC phenotype by testing the hypothesis that
RUNX3 regulates VSMC phenotypic modulation via suppressing myocardin/SRF-mediated transcriptional
activation of VSMC marker genes. Aim 2: Test the hypothesis that RUNX3 upregulates c-Myc expression
through NF-κB and GSK3β/β-catenin signaling to promote VSMC proliferation. Aim 3: Test whether RUNX3
is essential for carotid artery ligation/wire injury-induced vascular remodeling using global, VSMC-specific, and
endothelial cell-specific RUNX3 knockout mice. Taken together, this project will shed new lights on the
pathogenesis of vascular remodeling after vessel injury, which may ultimately lead to the identification of novel
targets for therapeutic treatment of various cardiovascular diseases related to vascular remodeling.

Public health relevance
Project Narrative Vascular smooth muscle cell (VSMC) phenotypic modulation, a phenotypic switch from a differentiated contractile phenotype to a proliferative phenotype, contributes to vascular remodeling and the development of diverse vascular diseases such as atherosclerosis, hypertension, and restenosis following angioplasty. We have uncovered a novel role of Runt-related transcription factor 3 (RUNX3) in VSMC phenotypic modulation and proliferation, implicating it in the development of vascular injury-related cardiovascular diseases. The proposed studies will shed new lights on the pathogenesis of neointima formation and vascular remodeling, which may ultimately lead to the identification of novel targets for the therapeutic treatment of cardiovascular diseases related to vascular remodeling.